Kansas Department of Agriculture's FSMA Human Foods Preventative Controls Implementation Expansion Supplement to RFA-FD-18-001

Project Summary The Kansas Department of Agriculture, Food Safety and Lodging Program (KDA-FSL) promotes food safety by establishing food protection standards, investigating complaints, educating food businesses and consumers, and licensing and inspecting food businesses. Entering into this cooperative agreement will allow our program to improve our Manufactured Foods Regulatory Program to incorporate the Preventative Controls for Human Foods (PCHF) rule, 21CFR Part 117. Through routine self-assessment, quarterly meetings, completion of mid-year and annual performance reports, and annually reviewing and updating our strategic plan, KDA-FSL will be able to assess our progress and refocus our work as applicable, so that at the end of this cooperative agreement, KDA-FSL will have completed the goals of the project. Goals that our program has set for this cooperative agreement include: • Incorporate the PCHF Rule, 21 CFR Part 117, into our implementation strategy of MFRPS, training, inspection, enforcement, auditing, laboratory/testing, and outreach programs • Improve our training and auditing programs to ensure a sufficient number of staff are qualified to conduct inspections under the PCHF Rule, 21 CFR Part 117 on risk-based inspection frequency • Build the infrastructure necessary for our manufactured foods regulatory program, including qualified personnel, IT resources, and regulatory authorities • Adopt regulatory authorities equivalent to the PCHF rules and associated Food Safety Monitorization Act rules. • Participate in data exchange between development/implantation with U.S. Food and Drug Administration (FDA) to enable necessary information exchange between U.S. FDA and state/Territory • Improve our programs capacity and expertise for conducting environmental and product sampling • Communicate with the U.S. FDA for information sharing coordination and leveraging of resources for regulatory work conducted under the authority of the PCHF rule

Public health relevance
Project Narrative Relevance The Kansas Department of Agriculture, Food Safety and Lodging Program (KDA-FSL) will use this Preventative Controls of Human Food (PCHF) implantation expansion supplement to establish a PCHF training coordination and monitoring program for our regulators. Incorporating PCHF into the program will allow KDA-FSL to maintain a high-quality manufactured food regulatory program and further develop processes and procedures. Our participation in this cooperative agreement will also contribute to the reduction of foodborne illness from food produced in Kansas.